INITIAL EVENTS IN THROMBUS FORMATION ON SURFACES

We wish to synthesize two type of novel polymers based on proven hypotheses and promising preliminary data. First, we propose the synthesis of multiblock copolymers which have hydrophilic-hydrophobic microdomain surfaces. Secondly, we will synthesis triblock-copolymers containing a hydrophobic block A (commercially available medical polymer), a hydrophilic block B(minimizing protein adsorption and platelet interactions) and a block C consisting of heparin (preventing fibrin formation). It has been shown by preliminary experiments that a multiblock copolymer, polyethylene oxide-polystyrene (PEO-PS) showed suppression of platelet aggregation. Triblock copolymers, PS-PEO-Heparin was biologically active when it was coated on PS surfaces and tested in vitro. The synthesized multiblock copolymers and triblock copolymers will be characterized using TEM, FTIR-ATR and contact angle measurement. Their nonthrombogenicity will be evaluated in vitro assay methods and in vivo using AV shunt rabbits and vascular implants in dogs.